Core A: Administrative

Core A Project Summary The overall objectives of Core A, the administrative core are to: (1) Provide budgetary and administrative support for each of the Projects; (2) Support the programmatic and synergistic activities of the research teams from across the Projects; and (3) Support outreach activities related to the project. These objectives will be accomplished by (a) providing overall administrative leadership for the Program Project. This will be the primary responsibility of the two PIs, Nathan Fox and Amanda Woodward; (b) creating an administrative structure for the Program Project. This structure will be required to serve the needs and develop the coordination of the different projects of the Program Project. It will consist of an executive committee and a steering committee; (c) creating an External Advisory Board that will provide input from outside scientists to the Center on the scientific and administrative issues associated with the Program Project. The advisory board will help guide the priorities we set for research and outreach initiatives for the Program Project. Establish rubrics for evaluation of Project and Core progress for formal evaluation; (d) overseeing all IRB activities related to the research programs which will allow data sharing across projects; (e) overseeing and monitoring the allocation of resources to each Project and Core; (f) facilitate cross-project interactions amongst postdoctoral fellows and graduate students; (g) coordinate yearly Program Project meeting for all personnel (and External Advisory Board); (g) coordinate outreach efforts across the projects; (h) maintaining and updating of the Program Project website, using it for messaging, file sharing, and outreach.